Mindful MAT Adherence: Mindfulness-Based Relapse Prevention (MBRP) to improve extended-release naltrexone (XR-NTX) adherence and drug-use outcomes for opioid use disorder (OUD).

PROJECT SUMMARY/ABSTRACT The aims of the parent-study are to determine whether an adjunctive Mindfulness-Based Relapse Prevention (MBRP) treatment program improves medication adherence and reduces drug-use among opioid use disorder (OUD) patients receiving Medication Assisted Treatment (MAT). The broad long-term objectives of this project are to investigate how integrative pharmacological and behavioral treatments improve OUD treatment outcomes. The aim of this Administrative Supplement to Existing NIH-NIDA Grants proposal is to enhance the focus on racial health equity issues within the context of the randomized clinical trial (RCT) parent-study. Although a strong evidence-base exists supporting MAT for OUD, Black Americans often contend with additional inequities and hardships that may render such approaches less effective. Specifically, exposure to racial discrimination and subsequent race-based traumatic stress has been linked to drug misuse among Black Americans. However, these specific variables have not been examined in the context of OUD treatment. Moreover, there is limited research investigating the general role of race as a moderating factor on OUD treatment outcome. Mindfulness (i.e., present-centered nonjudgmental awareness), associates with self-care and addiction severity among with SUD and has been observed to function as a resilience factor that moderates the relationship between exposure to racial discrimination and psychiatric symptoms. MBRP is an evidenced-based behavioral intervention that has demonstrated efficacy in reducing drug-use among patients in SUD recovery. There is a notable dearth of research examining the role of race, exposure to racial discrimination, and race-based trauma symptoms on OUD treatment engagement or drug-use outcomes. As there is reason to believe that the mindfulness training included in MBRP may address race-based trauma symptoms in addition to MAT adherence and drug-use outcomes, further research is critical to promote mental health equity among Black Americans. The primary study aim is to determine whether MBRP, compared to treatment-as-usual (TAU), delivered to Black OUD patients receiving MAT through enrollment in a residential addiction treatment facility, results in (1) improved MAT adherence, and reduced drug-use following residential discharge and (2) reduced race-based trauma symptoms. As race-based trauma symptoms are understood to associate with SUD severity, A second study aim will test the extent to which exposure to racial discrimination and severity of race-based trauma symptoms predict pre-treatment (1) OUD severity and (2) poorer treatment adherence and increased drug-use measured following residential discharge for Black TAU participants (but not Black MBRP participants). As prior trauma exposure is observed to undermine treatment efforts for SUDs a third exploratory study aim will determine the extent to which reductions in race-based trauma symptoms (pre-to-post MBRP) mediate beneficial outcomes for Black MBRP participants. Expected outcomes are that Black MBRP participants will demonstrate (1) increased MAT adherence and reduced drug-use monitored across 3-months post-treatment, (2) that reduced race-based trauma symptoms will partially mediate these outcomes, and (3) that prior racial discrimination and race-based trauma symptoms will moderate outcomes for TAU, but not for MBRP participants. Executing this supplemental research proposal will fill important knowledge gaps by clarifying the role that race and race-based trauma plays in OUD severity and treatment response, will solidify collaborative research efforts focused on mental health equity for Black Americans and will inform future preparation of proposals to secure federal funding to further this line of research.

Public health relevance
PROJECT NARRATIVE Numerous mental health disparities exist for Black Americans contending with substance use disorders (SUD) including, increased likelihood to incur negative consequences from substance misuse, lower rates of SUD treatment adherence and completion, and an escalation in rates of opioid deaths. Increasingly more research highlights the relationship between drug misuse and racial discrimination and race-based trauma symptoms. However, these variables have not been examined in the context of OUD treatment for Black Americans. In the context of a NIDA-funded clinical trial examining Mindfulness-Based Relapse Prevention (MBRP) for OUD, the present proposal will evaluate how race, race-based discrimination, and race-based trauma symptoms influence OUD severity, treatment engagement (i.e., adherence to OUD medication assisted treatment, MAT), and treatment outcomes (i.e., drug-use). Executing this supplemental research proposal will fill important knowledge gaps by clarifying the role that race-relevant variables play in OUD severity and treatment response and will significantly promote research activities needed to facilitate health equity for Black Americans.